(PQ12) Enhancement of DNA repair in neurons via a targeted APE1 small molecule modifier to decrease and reverse chemotherapy-induced peripheral neuropathy (CIPN)

PROJECT SUMMARY/ABSTRACT
Chemotherapy-induced peripheral neuropathy (CIPN) is a major side effect of many efficacious anticancer drugs,
including platinum drugs, taxanes, proteasome inhibitors, vinca alkaloids, epothilones, and immunomodulators.
Their neurotoxic side effects can be so debilitating that treatment may need to be reduced or stopped. However,
unlike other major side effects of chemotherapy (e.g. nausea, hair loss, bone marrow failure), no standard,
effective treatments exist to prevent or reverse CIPN. This is largely because the cellular mechanisms for CIPN
have not been identified and the symptoms of CIPN including numbness, decreased blood flow to extremities,
loss of proprioception, loss of tendon reflexes, pain, allodynia, and/or increased sensitivity to cold vary greatly in
patients. Because CIPN is debilitating and may be irreversible, identification of key targets to prevent
neurotoxicity without compromising the tumor-killing effects of anticancer drugs is critical in developing a first-in-
class therapeutic that can directly affect a patient's ability to receive optimal treatment. Our previous studies
examining the hypothesis that DNA damage of sensory neurons contributes to CIPN laid the foundation for the
proposed work, which is poised to develop a drug candidate. We demonstrated that reducing DNA base excision
repair (BER) activity by reducing expression of the apurinic/apyrimidinic endonuclease/redox factor (APE1)
augmented the neurotoxicity produced by anticancer treatment, whereas supplementing APE1's repair activity
attenuated the neurotoxicity. It is likely that, in non-dividing cells like neurons, DNA damage could alter the
function of sensory neurons in ways that manifest as the symptoms observed in CIPN. Consequently, DNA
repair would be critical for proper genetic expression of the right types and amounts of proteins, a crucial element
of genomic maintenance. For the proposed studies, we will examine whether augmenting APE1 repair
activity in vivo will prevent chemotherapy-induced alterations in sensory neuronal function (manifested
as CIPN) without jeopardizing the cancer treatment. Using tumor bearing mice, we will examine whether
a small molecule (E3330) which was identified to enhance APE1's DNA repair function in neurons can
prevent (aim 1) or reverse (aim 2) DNA damage and alterations in the function of sensory neurons caused
by cisplatin, oxaliplatin or carboplatin. Furthermore, we will examine whether the small molecule (E3330)
will compromise the anticancer efficacy of the platinum drugs by examining DNA damage and tumor
survival following treatment (aim 3). Because E3330 has been found to act as a single agent and in
combination with other cancer therapeutic drugs to decrease tumor cell growth, this molecule has the potential
to offer a “win-win” scenario; block tumor cell growth while protecting against neuronal dysfunction. Additionally,
E3330 will enter a phase 1 clinical trial for solid tumors followed by phase 1b/phase 2 trials for various indications
that include platinums in their SOC (e.g. colon, pancreatic). Therefore, it requires further preclinical study using
an in vivo paradigm to demonstrate effectiveness in the context of neuronal protection and CIPN models.

Public health relevance
Project Narrative Chemotherapy-induced peripheral neuropathy (CIPN) is a major side effect of a number of the most efficacious anticancer drugs, including platinum drugs, taxanes, proteasome inhibitors, vinca alkaloids and immunomodulators. The goals of this project are to test the efficacy of a targeted small molecule to prevent or reverse DNA damage and neurotoxicity induced by the platinum drugs in sensory neurons and to demonstrate that the small molecule does not compromise the anticancer efficacy of the platinum drugs in tumor-bearing mice. The results of these studies are of particular translational interest as the small molecule is already in phase I studies for anticancer activity and as there is no currently approved or effective agent to prevent or reverse CIPN.